Proteomic Profiling of Idiopathic Pulmonary Fibrosis Progression Trajectory

Project Summary
Idiopathic pulmonary fibrosis (IPF) is a devastating interstitial lung disease characterized by progressive lung
function decline survival worse than most cancers. Despite high mortality, the trajectory of IPF progression is
highly heterogeneous. This heterogeneity hampers drug development, as large sample sizes are required when
conducting IPF clinical trials to ensure enough patients experience forced vital capacity (FVC) decline to detect
a treatment effect. The ability to predict IPF progression trajectory, however, remains elusive. Emerging
proteomic platforms provide a valuable opportunity to address this gap in knowledge. In Aim 1, we will validate
proteomic biomarkers of IPF progression. Using a high-throughput, semi-quantitative proteomic platform, we
will determine plasma concentration for ~3000 analytes in the UK-based PROFILE cohort (n=550) and perform.
targeted analysis of 258 preliminary biomarkers of one-year categorical IPF progression identified in a discovery
cohort from the Pulmonary Fibrosis Foundation (n=813). In aim 2, we will derive and validate a proteomic
signature of FVC trajectory. Machine learning will be applied to semi-quantitative proteomic data to select
proteins for quantitative signature development. A custom, quantitative platform will be developed and used to
quantify selected proteins, with data used to develop a proteomic signature of one-year FVC trajectory. This
signature will then be assessed in three prospectively recruited IPF cohorts. In aim 3, we will determine whether
anti-fibrotic therapy modulates biomarkers of IPF progression. Quantitative proteomic data will be
generated for 240 treatment-naïve patients and repeated at 12-months after 80 patients each received
pirfenidone, nintedanib or no therapy. Longitudinal change in biomarker concentration and test performance
characteristics will be compared between treatment groups before and after anti-fibrotic initiation. Successful
completion of this proposal will identify novel molecular mediators of IPF progression and result in a highly
significant biomarker signature to predict IPF progression trajectory. This tool has high potential to speed drug
development through clinical trial enrichment, making precision medicine a reality in patients with IPF.

Public health relevance
Project Narrative In this proposal, we will identify proteins that predict different rates of progression in patients with idiopathic pulmonary fibrosis. Using protein data, we will also develop a protein signature to predicts near-term changes in lung function, which could speed drug development by reducing the number of patients needed for an idiopathic pulmonary fibrosis clinical trial.